FORUM ON NEUROSCIENCE AND NERVOUS SYSTEMS DISORDERS

The National Academies of Sciences, Engineering, and Medicine’s Forum on Neuroscience and Nervous System Disorders provides an important venue for candid discussions about emerging and critical issues among key stakeholders, including federal agencies that serve as research sponsors and regulators; the private sector; the academic community; and the nonprofit sector, including foundations and disease advocacy groups. The Forum’s activities serve to inspire new ideas and shape the field, foster relationships and collaboration, develop an improved understanding of each other’s perspectives and priorities, and influence policies and programs.